Role of BMP signaling in cardiac neural crest development

PROJECT SUMMARY/ABSTRACT
Congenital heart defects are the most prevalent birth defects observed in humans, several of which result from
abnormalities in an embryonic stem cell population called the cardiac neural crest (CdNC). These cells, which
originate in the vertebrate hindbrain, are characterized by their extensive migratory ability and capacity to
differentiate into numerous components of the heart, including cardiac ganglia and the smooth-muscle septum
between the aortic and pulmonary vessels. The mechanisms that govern CdNC derivation and spatiotemporal
differentiation remain largely a black box. However, observations from preliminary and historical work suggest
that the Bone Morphogenetic Protein (BMP) signaling pathway and cell-cell interactions between the ectoderm
and mesoderm play critical roles in modulating CdNC development and contributions to heart organogenesis.
The present study will leverage the unique strengths of multiple in vivo (chick and mouse embryos) and in vitro
(human embryonic stem cell) models to elucidate how BMP signaling is regulated intrinsically and extrinsically
to govern the derivation of the CdNC and its contributions to the heart. Aim 1 will define the role of the BMP
signaling antagonist, Noggin, which is specifically expressed in the CdNC, in establishing CdNC identity by
assessing the specification and behavior of chick and mouse neural crest cells in vivo following genomic
perturbation of Noggin, as well as by performing transcriptomic analysis of Noggin loss-of-function mutant cells
to identify downstream BMP target genes with altered expression. Aim 2 will uncover the gene regulatory
mechanism underlying the CdNC-specific expression of Noggin by using a two-pronged approach of knocking
out CdNC-specific transcription factors co-expressed with Noggin by CRISPR-Cas9, and site-directed
mutagenesis of a putative Noggin enhancer which perfectly mimics endogenous Noggin expression in the CdNC.
Additionally, Aim 2 will also explore a potential BMP signaling feedback loop and dose-dependent autoregulation
of Noggin expression within the CdNC. Aim 3 will unravel the molecular crosstalk between ectoderm-derived
CdNC and the mesodermal cells of surrounding tissues, particularly the somitic mesoderm, and unmask the
resulting impacts on CdNC cell fate, by employing novel in vitro cultures of human CdNC cells derived from
human embryonic stem cells. Taken together, these experiments will resolve how intrinsic genetic circuitry and
extrinsic molecular cues synergistically coordinate spatiotemporal patterning of CdNC cells within the hindbrain,
and their contributions to cardiovascular development. The completion of this project and the associated career
development plan will support Dr. Gandhi in his goal to become a principal investigator studying the etiology of
cardiac-crest-derived congenital defects in a manner that maximizes relevance to future therapeutic
applications.

Public health relevance
PROJECT NARRATIVE This project will unravel how intrinsic genetic and extrinsic signaling factors jointly regulate the formation of a specialized embryonic stem cell population called the cardiac neural crest, and its contribution to heart development. These advances will be accomplished by performing genetic perturbation studies on mouse and chick embryos, as well as human stem cell models, complemented by high-throughput sequencing data. The resulting findings may point towards new avenues for early detection and treatment of congenital heart defects.